Molecular Mechanisms of Apoptosis Regulation Through IP3 Receptors

Project Summary/Abstract
Inositol 1,4,5-trisphosphate receptors (IP3Rs) are the primary intracellular Ca2+ release channels in non-
excitable cells. IP3R activity drives numerous cellular processes including cell division, migration, mitochondrial
bioenergetics, autophagy, apoptosis and necrosis. Due to its diverse roles in cell fate decisions, it is perhaps
unsurprising that tumor cells can gain a selective advantage by co-opting and modifying the IP3R-mediated
Ca2+ signaling networks that underlie these processes. One mechanism that cells use to escape programmed
cell death is to increase expression of anti-apoptotic BCL2 proteins, including Bcl-2, Bcl-xL, and Mcl-1. Among
their various anti-apoptotic roles in cells, BCL2 proteins bind to IP3R and modulate Ca2+ dynamics. Despite
extensive characterization of the role of IP3R in apoptosis and the anti-apoptotic effects of BCL2-IP3R
interactions, mechanistic understanding of IP3R gating and modulation by BCL2 proteins is poorly understood
at the molecular level. It is clear, however, that BCL2-IP3R interactions promote cell survival in response to
apoptotic insult. Interactions between BCL2 and IP3R throttle the cell between enhanced mitochondrial
bioenergetics through activation of Ca2+-dependent enzymes and metabolites, and cell death through large
Ca2+ flux into the mitochondrial, leading to mitochondrial Ca2+ overload and outer membrane permeabilization,
the commitment step in apoptosis. In the proposed work, functional and structural approaches will be
employed to establish a mechanistic understanding of activation of IP3R by Ca2+ and IP3, and inhibition of IP3R
by high Ca2+ concentrations. Furthermore, through single channel studies and solution of a BCL2-IP3R
complex structure, a mechanistic basis for the regulation of IP3R by BCL2 proteins will be developed. The work
will provide a new framework by which we can understand IP3R-mediated cell death, paving the way for new
understanding and the design of therapeutics.

Public health relevance
Project Narrative: Cancer cells frequently co-opt and modify Ca2+ signaling networks to gain a selective advantage through up-regulation of anti-apoptotic BCL2 proteins, which bind to and modulate the activity of inositol 1,4,5- trisphosphate receptors (IP3Rs), the primary intracellular Ca2+ release channels in non-excitable cells. This study will employ a combination of structural and functional approaches to elucidate the molecular mechanisms of IP3R regulation by its physiological ligands IP3 and Ca2+, and determine how the anti-apoptotic BCL2 proteins modify its function to promote cell survival. The work will provide a new framework by which we can understand IP3R-mediated cell death, paving the way for new understanding and the design of therapeutics. !